Bruker Atomic Force Microscope NanoWizard® 5

Abstract
In this Shared Instrumentation Grant proposal, we request funds to substantially enrich and expand capabilities
of atomic force microscopy (AFM) based analysis of the single molecules, cells, and biomaterials at the University
of Texas Health Science Center at San Antonio (UT Health SA) in the Bioanalytics and Single-Cell Core (BASiC).
BASiC and its AFM laboratory is located in the Department of Molecular Medicine and it is a part of the
Institutional Research Core under the Office of the Vice President for Research. The proposed advancement
includes a purchase of the AFM system Nanowizard 5 from Bruker. The system will consist of a JPK
NanoWizard® V AFM head, JPK Vortis 2.1 SPM Controller with its advanced version option, and a JPK
HybridStage (200x200x200 µm³) mounted on a Nikon Eclipse Ti2-U inverted fluorescent microscope placed in
an acoustic enclosure on a benchtop active vibration isolation system. Further enhancements include a
microfluid system V2 FluidFM®, JPK Cell Mechanics Package and JPK SideView cantilever holder for
indispensable for single cell manipulations. The system will be supported by a number of essential AFM
hardware, accessories, tools, and specialized software for instruments control, data capture and analysis. The
BASiC AFM facility has been successfully serving the University community and beyond for ten years delivering
essential structural and mechanical data on cancer cells including patient isolated cells, organelles,
macromolecules and biomaterials supporting numerous publications, grant applications and other associated
activities. A broad array of basic, translational, and clinical studies at the UT Health SA depends on accessible,
affordable, and customizable AFM-based molecular and cellular imaging technologies including mechanical
phenotyping, chemical imaging and force spectrometry. The existing ten years old Nanoscope Catalyst is
inefficient with the current overload of patient, animal model, and biomaterial samples leaving no free time for
students training or critical methods development. Moreover, it cannot map medically crucial tissue, organoid
and spacious samples under the physiologically relevant conditions. It is also severely restricted in studies of
cell to cell interactions that are crucial for basic and medical studies. The current setup does not provide
capabilities for single cell liquid injection, sampling, and manipulation vital for all sequencing and hyphenated
applications interfaced with mechanical and fluorescent imaging. The Catalyst also shows a compromised
resolution of molecular objects comparing to the proposed Nanowizard 5. The Catalyst cannot be upgraded and
availability of its spare parts is limited. Therefore, the new proposed setup is indispensable not only to
accommodate the quantity of current research and preserve its quality, but also to enormously expand its
diversity and enhance its value that will benefit a broad spectrum of the biomedical users associated with the
greater San Antonio scientific community.

Public health relevance
Project Narrative In this proposal we request funds to expand capabilities of the UT Health San Antonio Bioanalytics and Single- Cell Core Atomic Force Microscopy Facility by acquiring the state-of-art Nanowizard 5 (Bruker) AFM. The proposed new setup will enable to rapidly acquire high quality data and probe and manipulate materials inaccessible with the current instrument for the benefit of the research aiming at improvement of human health.